Wyoming INBRE Administrative Core

SUMMARY: The Administrative Core is a mandatory core and, as in the past, will assume organizational
and accounting responsibilities for the Wyoming INBRE program. For INBRE-4 a new Student Program
unit will oversee all undergraduate and graduate programs. To meet the goal of a statewide initiative to
fully integrate and cross-fertilize biomedical research in Wyoming, the Administrative Core will be
composed of the INBRE Principal Investigator/Program Director, Program Coordinator, Student Program
Director and Fiscal Manager. With input from the Steering Committee, the External Advisory Committee
and the Developmental Research Project Program (DRPP) Scientific Advisory Committee, the
Administrative Core will be responsible for the overall management of Wyoming INBRE activities,
including coordination of animal and human studies to best promote translational research, allocation of
research funds to support thematic, pilot and other research projects, recruitment of research faculty
and coordination of career development (e.g., mentorship) for junior scientists, acquisition of
equipment, and improvement of infrastructure, and student programs. The ultimate goals of the
Wyoming INBRE Administrative Core are to continue to provide logistical support for the statewide
network comprised of the University of Wyoming as the lead institution and the Wyoming community
colleges as partner institutions, implemented during INBRE 1-3 to meet Wyoming INBRE’s Specific Aims.
The top priorities and major objectives of Wyoming INBRE 3 and the Administrative Core are structured
around the five specific aims of Wyoming INBRE: 1) continue to build on the established multi-
disciplinary research network with scientific foci that will build and strengthen biomedical research
expertise, education, training, and infrastructure at the University of Wyoming and its seven partner
institutions; 2) build and increase the research base and capacity of the University of Wyoming and its
partner institutions by providing research support to faculty, postdoctoral fellows and graduate
students; 3) provide research opportunities for undergraduate students that will create a pipeline for
undergraduate students to continue in health research careers within IDeA states; 4) enhance the
science and technology knowledge of the state's workforce; and 5) expand Wyoming research
opportunities across the Western IDeA Region.